Apical extracellular matrix during organ formation

PROJECT SUMMARY
Many organs in the human body, such as the kidneys, lungs, and digestive organs, are organized as
three-dimensional tubular structures. Abnormal tube size leads to defects in organ formation, such as
polycystic kidney disease and pulmonary agenesis (underdeveloped lungs). There is increasing evidence
that the apical extracellular matrix (aECM), the extracellular layer on the apical (luminal) side of epithelia,
actively contributes to epithelial morphogenesis. Studies in C. elegans and Drosophila have identified the
aECM as a critical regulator of tube expansion and elongation and have shown that post-translational
modifications of the aECM are essential for correct tube dimensions. However, very little is known about
the structural components and biological functions of aECM, and the mechanisms of tube size control by
aECM remain largely unknown.
The Drosophila embryonic salivary gland (SG) is an excellent system to study aECM and tube
dimensional control. From our pilot screen in the Drosophila embryonic salivary gland (SG) to identify
key enzymes that affect SG morphology, we have identified Papss, an enzyme synthesizing an activated
sulfate donor compound, as a critical regulator of SG lumen expansion. Sulfation is one of the most
common post-translational modifications of ECM components. Defects in sulfation lead to many human
diseases, such as bone and joint abnormalities and eye disorders. How sulfation affects the formation of
internal tubular organs is unknown. Our initial analysis revealed that Papss mutants have a defective,
condensed aECM in the SG, which is associated with disrupted Golgi structure. We also identified zona
pellucida (ZP) proteins and mucins as critical aECM components for proper SG lumen morphology. In
the proposed studies, we will elucidate the mechanisms by which the aECM and its modification regulate
the dimensions of tubular organs and to identify/characterize key aECM components. First, we will
elucidate the mechanism by which Papss regulates the aECM. Second, we will dissect the role of ZP
proteins and mucins in the SG aECM.
The powerful genetics combined with state-of-the-art microscopy make the Drosophila SG an
excellent model to address these questions. Members of my lab have expertise in genetics, cell and
developmental biology, and advanced microscopy techniques, and we are well equipped with the
necessary instrumentation. The proposed work will help elucidate how organ precursor cells generate
and modulate their extracellular environment, and how the extracellular environment influences tissue
morphogenetic processes. We expect these studies to be generally applicable to the development and
function of human organs.

Public health relevance
PROJECT NARRATIVE Making a three-dimensional tube is a fundamental process in formation of many organs, including lungs, kidneys, and digestive organs. We aim to understand the molecular mechanisms of how the apical extracellular matrix regulates tube dimensions in the Drosophila (fruit fly) salivary gland, a relatively simple but genetically powerful system. Our work will provide us with insights into understanding the regulatory mechanisms of normal organ development and human disorders linked to the malformation of a tube.